Randomized Control Trial of the Co-Parenting for Resilience Program

Project Summary
Parental divorce can negatively affect children in ways that are often severe and long lasting. Approximately
25% of the children of divorcing parents have major long-term mental and behavioral health problems
compared to approximately only 10% of children in the general population. Even among those who ultimately
adjust well, many will experience considerable emotional distress which can lead to maladaptive coping and
negative outcomes such as antisocial behavior, depression, school dropout, substance use and precocious
sexual activity. In response to the effects of divorce on children, brief prevention interventions focused on
teaching parents how to ameliorate the impact of divorce on their children have gained widespread acceptance
by court systems across the nation, and online versions of the same have proliferated during COVID-19.
However, recent systematic and metanalytic reviews reporting on the efficacy of divorce education programs,
while showing promising results, generally lack the methodological rigor to form the strong empirical foundation
needed to advance the field in both theory and practice. To address these weaknesses, the current project
tests Co-Parenting for Resilience (CPR), a divorce education program that draws on theories from the field of
Marriage and Family Therapy and Prevention Science to incorporate empirically-supported therapeutic
strategies into a 4-hour psychoeducational workshop. Building upon our previously successful trial using a non-
equivalent control group, the proposed study uses a 3-arm (CPR in-person, CPR online, and bibliotherapy
attention placebo control) randomized controlled trial with an intent to treat design. The study collects a sample
of 300 parents who have recently filed for divorce to accomplish the following three aims: 1) Determine the
relative efficacy of the online and in-person versions of CPR to improve child post-divorce adjustment
compared to each other and to a bibliotherapy control group at 3- and 12-month follow-ups; 2) Test paths from
the online and in-person versions of CPR to child adjustment via parenting competencies; and 3) Identify
moderators of the effectiveness of in-person and online formats of CPR such as parent gender, ethnicity, and
level and type of conflict between divorcing partners. If accomplished, these aims will provide insight into
whether: (a) remitting couples to a divorce education class is more effective than simply reading a book on
divorce, (b) in-person or online delivery formats are more beneficial in helping parents overcome the parenting
challenges of divorce, and (c) there are subgroups for whom divorce education is more or less effective.

Public health relevance
Project Narrative Public Health Implications. The negative effect of divorce on children coupled by the sheer number of divorces involving children each year constitutes a public health crisis. If effective, this project will provide evidence for the use of divorce education programs as a low-cost, scalable, and sustainable intervention to ameliorate the negative emotional and behavioral health impacts of divorce on children, while providing an empirical foundation that will help move the field of divorce education forward and maximize the benefit of these interventions with children and their parents.